Licensure and Inspection System database for inspection, investigation and enviro

SDDOH seeks to implement a statewide electronic licensure and inspection system for regulated food service, lodging, and campground establishments. The system would establish the ability to rapidly communicate with regulated establishments as well as inspection personnel. Near, real-time inspection results along with associated GIS data would allow SDDOH to identify potential food defense issues. GIS data would also allow targeted and rapid electronic communication should substantiated threats to the food supply be identified. The system would also establish a method of routine communication with regulated establishments allowing for enhanced education and awareness of food defense practices.

Public health relevance
It's important for public safety and defense to take a proactive approach to maintain the integrity of our state's food production and distribution network. An integrated electronic inspection system allows for accurate and immediate data collection and distribution. This allows the department and other agencies to act quickly and protect the public in the event of an incident or outbreak by containing the situation.